Evaluating the impact of e-cigarette social media marketing on e-cigarette use among underage youth.

Abstract/Project summary
E-cigarettes are a big problem among high school students – with rates of daily use exploding from 12% in 2017
to 28% in 2019. Adolescents are exposed to e-cigarette endorsements from social media influencers who
promote these harmful products on behalf of e-cigarette brands as a healthier alternative to conventional
cigarettes. This project proposes to comprehensively describe e-cigarette influencer marketing on Instagram
(the most widely used platform for e-cigarette influencers) and on other social media platforms popular among
U.S. teenagers; to examine associations between exposure to social media marketing and patterns of initiation
and change in e-cigarette use; and to explore youth attitudes and ideas related to e-cigarette influencers and e-
cigarette prevention campaigns. For Aim 1, we will use innovative, validated deep-learning models - a form of
artificial intelligence that automatically discovers patterns in data - to evaluate trends in marketing themes and
compliance with federal requirements for warning labels and sponsorship disclosures in e-cigarette promotional
images and videos on Instagram, YouTube and TikTok to be collected from 2021 to 2023 (over four million posts,
in all). We will use ANOVA tests to examine temporal trends in user engagement with e-cigarette marketing
posts and compare the proportion of underaged users among followers of e-cigarette influencers on these
platforms over the two-year period. For Aim 2, we will measure the association of exposure to e-cigarette
marketing (on Instagram, YouTube, TikTok and Snapchat) with subsequent initiation, escalation or cessation of
e-cigarette use among a socioeconomically- and racially-diverse cohort of 5,000 high school students living in
urban areas of Southern California via ongoing longitudinal cohort surveys (2021-2023). We will use three waves
of survey data in multilevel multinomial logistic regression to measure changes in exposure to- and engagement
with e-cigarette marketing on Instagram, YouTube, TikTok and Snapchat; we will use repeated-measures
random effects logistic regression models to evaluate the association of exposure to marketing content on these
platforms with subsequent changes in e-cigarette use. Ten focus groups among survey participants will
complement survey findings and will be analyzed using the Grounded Theory method. Using the social media
data, surveys and focus groups, we will also quantify and characterize the level of exposure to- and perception
of anti-e-cigarette prevention campaigns on social media. This project will be the first to thoroughly evaluate
changes in e-cigarette use habits among youth as a result of exposure to e-cigarette marketing and interaction
with e-cigarette influencers on the most popular social media platforms among adolescents.

Public health relevance
Project Narrative Despite federal regulations, influencers continue to promote e-cigarette products on Instagram and other social media platforms popular among teenagers such as TikTok, YouTube, and Snapchat. This will be the first study to comprehensively evaluate user engagement with e-cigarette influencers, changes in youth e-cigarette use resulting from exposure to- and engagement with e-cigarette marketing content, trends in e-cigarette marketing themes, and compliance with federal regulations for e-cigarette warning labels and sponsorship disclosures. Our findings will allow us to inform regulators about the influence of social media promotional strategies on youth susceptibility to e-cigarettes to help design future public health e-cigarette prevention campaigns that can counter e-cigarette marketing.